DNASE1L3 regulation of anti-tumor immune responses following radiation therapy

Project Summary
The critical preliminary data for this proposal relates to dendritic cells, a critical immune cell that links innate
detection of infection to adaptive immune responses that can uniquely target and destroy targets. These same
principles apply to initiate and control immune responses to cancer. We discovered that in tumors that are
unable to generate adaptive immunity to assist in tumor cure following radiation therapy, dendritic cells fail to
mature. These dendritic cells that fail to mature express a novel target gene called Dnase1l3, which has been
shown to negatively regulate innate stimuli, and to negatively regulate autoimmune responses. This proposal is
an innovative investigation into the role of this gene in anti-tumor immunity, and the mechanisms by which it is
regulated in dendritic cells in tumors.
We hypothesize that DNAse1l3 represses innate and adaptive immune responses in the tumor environment.
The specific aims of this study are to 1: Determine the consequence of myeloid expression of Dnase1l3 on
the immune response to radiation therapy; 2: Unbiased analysis of the consequence of myeloid expression of
Dnase1l3 on the tumor immune environment following radiation therapy. Our study design incorporates CT-
guided radiation therapy of multiple authentic pancreatic tumor models and using a range of RT doses and
fractionations. These are combined with unique knockouts and assays that allow us to identify divergent
responses in vitro and in vivo. Our analyses of clinical samples use high quality bioinformatic approaches that
allow us to evaluate effect of the tumor environment on the biological response to innate adjuvants in patient
samples.

Public health relevance
Project Narrative The fact that two different cancer patients can respond differently to the same therapy represents an important problem in cancer treatment. Using in depth analysis of responsive and unresponsive tumors, we have identified a novel target with the potential to help those with non-responsive tumors. We use unique and high quality preclinical models to evaluate the impact of this target on outcome, and use advanced analysis of tumors to understand the molecular regulation of the target.